The Role of Foot Structure and Function on Walking Mechanics and Energetics in Aging

PROJECT SUMMARY
Older adults exhibit a substantial reduction in propulsive power generation. This change in walking mechanics
is associated with slower walking speeds and greater metabolic energy expenditure – features that negatively
affect independence and quality of life. Age-related reductions in propulsive power are often attributed to
reduced ankle mechanical power during the ‘push-off’ phase of walking. Yet, strengthening the calf muscles has
been an ineffective strategy for improving push-off intensity, walking speed, and/or metabolic cost, motivating
the need for new and modifiable targets for preserving mobility in our aging population. Recent studies have
determined that the foot, independent of the ankle, plays a critical role in governing push-off intensity. The
interaction between active structures (e.g. muscles within the foot) and passive structures (e.g. plantar
aponeurosis – an elastic structure spanning the bottom of the foot) of the foot are vital to economic locomotion,
but it is unclear how this interaction facilitates forward propulsion, or how this interaction is changed with age.
We propose that age-related changes in passive and active contributions to foot stiffness may contribute to
reductions in push-off intensity in older adults, both directly via deficits in foot power and indirectly via the
misappropriation of ankle power. Aim 1: Our proposal will leverage a novel dual-probe ultrasound imaging
technique to determine the role of foot stiffness and plantar intrinsic muscle contractile dynamics in governing
foot-ankle interaction dynamics in young adults. Aim 2: We will then characterize the local energetic and
mechanical response to changes in plantar aponeurosis stiffness by closely integrating our experimental data
from Aim 1 into a computational model of the lower extremity. Aim 3: Finally, we will determine the effects of
age on foot stiffness and its role in walking economy and functional mobility. This study has the potential to
influence a paradigm shift in our biomechanical understanding and clinical management of age-related mobility
impairment. Moreover, our findings will have immediate impact on targeted mobility intervention opportunities
and innovation in the design of wearable integrated foot and ankle devices for enhanced mobility toward
improving the health and welfare of our aging population. Finally, our technological advancements in
musculoskeletal imaging will revolutionize the use of in vivo ultrasound during functional locomotor behavior,
with broad implications in humans and other animals.

Public health relevance
RELEVANCE TO PUBLIC HEALTH The premise of this study is that the interaction between foot-ankle structure and function is a poorly understood, yet vastly important, biomechanical mechanism that influences walking ability and may be uniquely compromised with aging. The experimental approach combines novel dual-probe ultrasound imaging, computational modeling, and electromyography techniques to uncover the mechanisms underlying age-related differences in propulsive power during walking. The expected results will have an immediate impact on our understanding of musculoskeletal mechanisms underlying age-related mobility impairment toward improving the health and welfare of our aging population.